Elucidating the role of gut microbiota in colitis-associated colorectal cancer

Abstract
Patients with ulcerative colitis (UC), an inflammatory bowel disease (IBD), have an increased risk of developing
colitis-associated colorectal cancer (CAC). Human gut microbiome composition has recently been associated
with a wide array of diseases, including IBD and colorectal cancer. Studies have shown that gut microbiota
could influence colon epithelium to initiate or promote colorectal cancer development directly or indirectly.
However, little is known on the structure and function of the microbiota in CAC and how they implicate the
development of CAC at the molecular level. In this study, we will investigate the role of microbiota in the
development of CAC, as well as the molecular events underlying the interplay of microbiota and host response.
The project builds upon our previous studies in examining the genomic instabilities and proteome alterations in
the colon epithelium during the pathogenesis of IBD-CAC, and will focus on the mechanistic and functional
involvement of the microbiome and their components in the modulation (by protective bacteria) or activation
(by tumorigenic bacteria) of CAC development. Specifically, we will investigate the implication of mucosa-
associated microbiota in CAC by an integrated approach using three model systems, including clinical
specimens (Aim 1), in vitro microbial cultivation and organoid models (Aim 2), and in vivo mouse model (Aim
3). Our integrative, state-of-the-art approach will characterize the composition, functional genes and pathways
of the microbiome implicated in CAC, and the impact of microbiota on colon mucosa. By studying the gut
microbiota and its interplay with the colon host using novel approaches and cutting-edge technology, our study
has significant translational potential that could lead to establishing the gut microbiome as predictors of CAC
risk and aid in developing approaches for CAC prevention and detection in IBD patients.

Public health relevance
Project Narrative Human gut microbiome composition has recently been associated with a wide array of diseases, including inflammatory bowel disease (IBD) and colorectal cancer. We propose to study the structure and function of the gut microbiota in the development of IBD associated colorectal cancer. Our proposed study may lead to better understanding of the interplay between gut microbiota and colon mucosa and could shed light to novel diagnostic and therapeutic approaches to IBD and associated colorectal cancer.